American Society for Neurochemistry Annual Meeting 2023

PROJECT SUMMARY/ABSTRACT
This R13 application is for support of the 53rd annual ASN meeting to be held in Lexington, Kentucky from
March 18-22, 2023. The total expected attendance for 2023 meeting at Lexington, KY is ~ 400. Due to the
past NIH funding support, we have been able to accomplish goals of enhancing training for future
neurochemistry researchers, and for ensuring adequate support for the educational program. ASN continues
to build its scientific program around four distinct but complimentary themes to accommodate the breadth of
neurochemistry and discuss in detail the most recent updates on: 1) Glial Mechanisms & Injury, 2) Building the
Nervous System,3) Neurodegeneration and Disease, and 4) Metabolism, Cellular, & Molecular Neurobiology.
We have selected these themes to increase our understanding of the cellular and molecular basis of neural
development in the periphery and central nervous system to understand the basic biology and disease. Each
theme has one of the four Plenary/Presidential speakers and is represented in varying proportions each year
based on the submission of session proposals from the ASN membership and neurochemistry community.
ASN is strongly committed to the representation of women, underrepresented minorities, and persons with
disabilities at its meetings. Two of the four Plenary/Presidential speakers are female, 60% of the Chairs/Co-
Chairs of Symposia and Colloquia are female, 50% of the Speakers of Symposia and Colloquia are female,
while 15% are from underrepresented minorities. One of the major goals of ASN is to advance the education
and recruitment of young investigators. The ASN strongly supports young investigators through travel awards,
mentorship, and various training workshops. In addition, representation of trainees/junior faculty in Symposia
and Colloquia is 40% for Chairs/Co-Chairs and 45% for speakers.
The annual ASN meeting provides participants numerous opportunities to network, collaborate, and exchange
ideas. In addition, there are numerous opportunities for attendees to congregate informally. There are also has
multiple mechanisms to enhance professional development of young investigators during the meeting: 1) career
development sessions run by the young investigator committee, 2) a student/postdoctoral fellow mingle for
networking, 3) Participation in Public Forum, High School Day, and Women in Neurochemistry Lunch Session,
4) oral sessions selected from submitted abstracts, with an emphasis on presentations from trainees, 5) to
defray costs of attendance travel awards for outstanding junior scientists are available. This year we have
increased the number of awards and assigned nearly 1/3rd of the awards for under-represented minorities and
persons with disabilities as an impetus to further promote and retain diversity, and 6) a job- posting site and
opportunities for trainees to meet with potential future mentors or colleagues. The annual ASN meeting one of a
kind meeting that brings bring together young and seasoned scientists together to experience cutting edge
neurochemistry and neurobiology, and for enhancing the careers of young investigators.

Public health relevance
Project Narrative The goal of the 2023 American Neurochemistry Society meeting is to bring together members of the scientific community to navigate and cross-fertilize the fields of neurochemistry and neuroscience in these changing times. It is imperative to increase diversity and provide all junior investigators and trainees (who are the future of science) with a forum for the open and free exchange of ideas and mentoring which is fostered by the highly specialized topical and organizational format of the ASN meeting.